PD-L1 Signaling in Phagosomes

Host defense against microbial infection and pathology relies on immune responses that are activated by host receptors that recognize diverse microbial components and opsonins. Over the last 20 years remarkable progress has been made in developing this principle, and the body of literature documenting how receptors such as Toll-like receptors and C-type lectin receptors function is a testament to this progress. In this project, we are investigating how the process of phagocytosis by cells such as macrophages is a mechanism of innate sensing. Specifically, we have recently found that degradation of yeast in macrophage phagosomes reveals novel ligands for receptors including PD-L1. In this project, we will explore how this binding occurs and the identities of the ligand or ligands that are recognized.

Public health relevance
Surviving in a world suffused with fungi requires development of innate and adaptive immune capabilities for defense against pathogenic and commensal fungi. This project examines the role of recruitment of proteins like PD-L1 to phagosomes containing yeast in orchestrating successful immune defense against fungal infection. Modified Project Narrative Section Host defense against fungal infections begins with innate immune receptors on myeloid phagocytes that detect fungi and trigger inflammatory responses. Immune cells including macrophages and dendritic cells can “eat” yeast and kill them, and this project focuses on understanding how this process, called phagocytosis, contributes to inflammation during fungal infection. Modified Title Section PD-L1 Signaling in Phagosomes